Administrative Core

PROJECT SUMMARY - CORE A
The Administrative Core (Core A) will be responsible for coordinating activities among the three Projects and
scientific Core Units, the financial management of the Program and other administrative responsibilities. Since
Program Project Grants involve multiple projects, cores, laboratories and investigators, a centralized mechanism
to facilitate PPG operations is required. Overall, Core A will ensure synergy between the Projects, facilitate
progress, ensure wide dissemination of scientific findings and ensure data validity and integrity.
Specifically, the goals of Core A are:
1. Scientific: Coordinate formal and informal reviews of the Program and meetings involving Program
scientists. Facilitate scientific progress towards the goals of the Program
2. Management: Ensure data validity and integrity. Assume responsibility for the financial management of
the Program. Provide support for office and account personnel related to the Program. Provide
computer support for Program scientists.